2023 Lung Development, Injury and Repair Gordon Research Conference and Gordon Research Seminar

Project Summary:
The 2023 Lung Development, Injury and Repair Gordon Research Conference (GRC) and associated Gordon
Research Seminar (GRS) will be held August 12-18, 2023 in Waterville Valley, NH. The theme for the 2023
Lung GRC is "Post-COVID Return to Respiratory Health". The 2023 Lung GRC comes at a critical time,
because post-acute COVID-19 syndrome including chronic consequence of severe lung injuries will be coming
into focus, heightening our need to understand and combat the dysfunctional repair and remodeling that
follows severe injury. According to statistics from the World Health Organization, the global burden of lung
disease continues to rise, with >4 million deaths annually worldwide attributed to chronic respiratory diseases,
including COPD, asthma, and pulmonary fibrosis. While basic scientific research is making substantial strides
forward in understanding molecular, cellular and tissue level mechanisms driving respiratory diseases,
translation of these findings toward early detection and effective repair and restoration of lung function in
chronic respiratory diseases remains a major barrier. Meeting this challenge requires the integration of
knowledge from experts spanning lung development, molecular and cell biology, genomics and epigenomics,
physiology, bioengineering, matrix biology as well as physicians and translational experts immersed in the
diagnosis and treatment of human disease. Lung GRC/GRS 2023 will bring diverse experts together to
disseminate and debate the latest findings in the fields of lung development, injury and repair, and to formulate
new ideas, collaborations and approaches that will translate biologic discoveries toward meaningful advances
in respiratory medicine. A major emphasis of the Lung GRC and GRS is to strengthen the pipeline of scientists
and clinicians focused on lung development, injury and repair. Funds from this R13 will be specifically targeted
to promote participation in the conference by women, under-represented minorities and people with disabilities,
graduate students, postdoctoral fellows, and early career investigators. The unique attributes of the GRC (open
scientific exchange, secluded location to maximize engagement, tradition to share unpublished data, abundant
time for discussion) and GRS (close trainee interactions with peers and mentors) provide an opportunity for
formal and informal interactions and collaborations that are likely to have significant and sustained impact on
the field. The 2023 Lung Development, Injury and Repair GRC/GRS will thus promote accelerated progress in
understanding and treating chronic lung diseases, and help to ensure the vitality and growth of a diverse
pipeline of clinicians and scientists capable of addressing the growing burden of lung diseases.

Public health relevance
Project Narrative: The 2023 Lung Development, Injury and Repair Gordon Research Conference and associated Gordon Research Seminar will provide a much-needed forum for discussing the latest advances in lung biology and catalyze efforts to move these discoveries toward returning to lung health in this post-COVID era. Active participation by a cohort of emerging leaders at the conference, with an emphasis on promoting diversity, is critical for building a strong pipeline of the next-generation scientists and clinicians capable of addressing the growing burden of lung diseases.